Monitoring mosquito eco-systems and vector-control strategies using a stand-off optical sensor.

Monitoring mosquito ecosystems and vector-control strategies using a stand-off optical
sensor.
PI: B. Thomas – NIH R21
Project Summary:
Vector control strategies remain one of the most effective ways to protect human populations from the
large number of mosquito borne diseases such as malaria, dengue fever, zika virus, or West Nile virus.
Mosquito populations are generally monitored using physical traps, however this method suffers from many
disadvantages. It requires long and expensive laboratory analysis by qualified personnel which drastically
reduces the number of observed insects as well as time of trap deployment. Traps also provide a poor estimate
of the actual population size or population density because the attractive range of traps is generally unknown
and may change with weather conditions. These limitations are strong drawbacks in our ability to evaluate the
effectiveness of various types of vector-control strategies (chemicals, biological, environmental modifications
etc.). Inferior methods are not necessarily identified which ultimately contributes to the spread of infectious
diseases. In this context, we argue that new methodologies to monitor insect population dynamics is key in the
necessary effort to improve control program performance.
A team from the New Jersey Institute of Technology in collaboration with the Hudson Mosquito
Program seeks support to carry out a series of field experiments using a new optical sensor capable of
identifying in real-time the family, species, and gender of mosquitoes in its field of view. The laser-based
instrument is a dual-wavelength polarization-sensitive stand-off sensor. For each flying insect transiting
through the infrared laser beams, the sensor can retrieve the optical properties of the wings and body of the
insect as well as its wing beat frequency. Preliminary data from a laboratory prototype and numerical
simulations indicate that the instrument, using a supervised machine learning classifier, can identify the
species, gender, and gravidity of mosquitoes up to 300 m away. The instrument will be deployed in a high
mosquito density area in New Jersey to continuously monitor the mosquito population over the whole season
from April to October 2021. Continuous measurements will allow to identify a number of insects that is orders
a magnitude higher than physical traps. As the probed volume of air is known, data analysis will provide the
population density for each class of insects from which the population dynamics will be derived. In addition,
the time and date of each insect transit allow to study the circadian rhythm, peak activities, and behavior as a
function of atmospheric conditions measured by a weather station. In 2022, a similar experiment will be
conducted at the same location while the Hudson Mosquito Program will conduct a vector control campaign
targeting Culex and Aedes mosquitoes, both responsible for the spread of various infectious diseases. The
impact of multiple applications of airborne pyrethroid insecticide on targeted and non-targeted insects will be
evaluated by studying the mortality rates and population dynamics for each species. Both years, the data will be
compared to physical traps on site, the current gold standard method, for further analysis and validation.

Public health relevance
Project Narrative Mosquito-borne diseases are a major challenge for Human health as they affect nearly 700 million people every year and result in close to one million deaths; however, lack of reliable data on mosquito populations has become a serious obstacle to evaluate the effectiveness of vector control programs. The proposed study will make use of a new methodology based on applied optics to remotely count and identify in real-time the species and sex group of flying mosquitoes in their natural habitat. This novel methodology will be used to evaluate the impact of insecticide applications on the population dynamics of key vector of infectious diseases.